Interactions of MG53 and GsdmD for Neutrophil Pyroptosis Inhibition

Project Summary/Abstract
The proposed research project aims to understand how MG53, a membrane repair protein, protects heart cells
after myocardial infarction (MI). When MI occurs, it causes inflammation and damage to heart cells, which can
lead to further complications if not controlled.
The project focuses on a process called pyroptosis, which is a type of cell death that contributes to inflammation.
MG53 is known to help repair damaged cell membranes, while another protein, GsdmD, forms holes in cell
membranes, leading to membrane rupture and subsequent cell death. The central hypothesis is that MG53
may prevent this harmful process by interacting with GsdmD in neutrophil cells.
The long-term goal is to find a way to fine-tune the immune response to promote healing after MI without
causing excessive inflammation. Preliminary data suggest that (1) Pyroptosis plays a key role in the inflammatory
response shortly after MI. (2) MG53 reduces GsdmD activation and pyroptosis and improves heart damage after
MI. (3) Activated GsdmD is found in neutrophils after MI.
Since MG53 is naturally present in the body, targeting it for therapy should be safe and not trigger an immune
reaction. The hypothesis is that MG53 prevents pyroptosis by interacting with GsdmD in neutrophils, stopping
GsdmD from activating or blocking the holes activated GsdmD creates.
The research will have two main Specific Aims. Aim 1: To study how MG53 and GsdmD interact before and after
GsdmD activation. Research design and method: Aim 1 will investigate the binding of MG53 and GsdmD in
solution and MG53’s and activated GsdmD’s colocalization on liposomes. Aim 1 will also employ an MG53
mutant that lacks membrane repair function to elucidate MG53’s role in protecting neutrophils after pyroptosis.
Aim 2: To determine if neutrophil pyroptosis contributes to heart cell death. Research design and method: Aim
2 will assess the contribution of neutrophil pyroptosis to post-MI cardiomyocyte death by utilizing neutrophil-
specific GsdmD knockout mice for post-MI evaluation and by evaluating if recombinant MG53 can protect
cardiomyocytes from neutrophil pyroptosis.
This research could lead to new therapies for treating MI by reducing damage and promoting healing.

Public health relevance
Relevance to Public Health Myocardial infarction (MI), a leading cause of mortality and morbidity worldwide, causes significant pyroptosis- induced inflammation in the heart. The proposed project aims to elucidate the protective role of protein MG53 against post-MI inflammation. The research outcome shall have significant translational values in developing potentially effective therapies to treat MI by reducing post-MI inflammation.